Bioengineering a human microphysiological system for elucidation of viral peripheral neurotropism of RSV and SARS-CoV-2

PROJECT SUMMARY
Chronic neurological impairments are a widespread consequence of both the SARS-CoV-2 pandemic
and the subsequent surge in RSV that will place a lasting burden on healthcare systems worldwide. This
includes both purely cognitive symptoms (sleep disruption, confusion, and brain fog) as well as symptoms of
peripheral and autonomic neuropathy (shortness of breath, intractable cough, headache, and stroke). While
the blood-brain barrier protects central nervous system (CNS), the peripheral nervous system (PNS) is more
directly exposed to pathogens both in the nerve terminals innervating the upper respiratory tract and through
the general circulation. Unfortunately, viral invasion of the PNS is vastly understudied despite its constant
exposure to pathogens and critical role in the regulation of normal bodily functions.
Using innovative neural microphysiological systems (MPSs), we have recently demonstrated that RSV
infects both monocytes and neurons in peripheral nerve tissue, generates concerted chemokine release, and
dose-dependently induces nerve hypersensitization or progressive neurotoxicity. Both neuronal infection and
inflammation-mediated neuropathy are novel observations that could explain analogous mechanisms of
peripheral neuroinvasion in humans that may contribute to sudden apnea experienced by infants exposed to
RSV in utero, chronic airway hyperreactivity in children exposed to RSV in the perinatal period, and the
persistent peripheral neuropathy and autonomic dysfunction associated with long COVID. Critically, MPSs
support the use of rodent, human stem cell-derived, or primary cell types within the same model system,
facilitating comparison of analogous data across species towards translation of basic research findings to the
clinic.
The development of bioengineered models of the PNS and likewise the methodologies necessary for
efficient, repeatable data extraction specifically from microphysiological peripheral nerve has received
considerably less attention than analogous models of the CNS. Here we propose to establish the conditions
necessary to facilitate interaction between peripheral neurons, glia, and inflammatory cells in
microphysiological culture to advance the meaningful complexity of microphysiological PNS modeling. We
also aim to identify the most stable and sensitive optogenetic tools for long-term longitudinal collection of
neurophysiological data to maximize the utility of this MPS for detection of viral neuropathy. We will then
demonstrate the utility of the system by using it to compare peripheral neuropathy resulting from direct
exposure to RSV and SARS-CoV-2. Completion of these goals will establish the feasibility of a novel, human-
based MPS capable of elucidating peripheral neurotropism of known and emerging viruses.

Public health relevance
PROJECT NARRATIVE Chronic neurological impairments are a widespread consequence of both the SARS-CoV-2 pandemic and the subsequent surge in RSV that will place a lasting burden on healthcare systems worldwide. Here we propose to advance the meaningful complexity of human cell-based microphysiological peripheral nerve modeling and demonstrate its utility for detection of peripheral neuropathy induced by viral neuroinvasion. Completion of these goals will establish the feasibility of a novel, human cell-based “nerve-in-a-dish” model system that will make it easier to study viral interactions with nerves for known and emerging viruses.